Vascular mechanisms and tDCS treatment of gait and posture in aging and age-related diseases

My career goal is to become a leading academic scientist with a research focus on the
neurophysiology of balance disorders in aging and age-related disease. I will achieve this goal by
leading a translational research program aimed at identifying the pathophysiological manifestation
of aging and age-related disease that diminish the control of walking and standing, and their
consequences on important clinical outcomes such as mobility. I will also work to translate
these discoveries into future clinical interventions and practices that will improve
mobility and quality of life within these populations.

The control of gait and posture is dependent upon cognition and is linked to prefrontal brain
function in healthy adults. The K99 phase research was designed to, for the first time, study the
effects of aging, type 2 diabetes mellitus (DM) and Alzheimer's disease (AD) on prefrontal brain
activation during standing and walking. Both DM and AD exaggerate age-related declines in gait and
posture, and it is expected that this is caused at least in part by shared cerebrovascular
complications; namely, a reduced ability to sufficiently activate the prefrontal cortex during
these activities due to decrease blood flow and increased vascular resistance. With this
information in hand, the proposed R00 phase research will then attempt to increase
prefrontal brain activation using transcranial direct current stimulation (tDCS) in order to
improve walking and standing in these patients. Thus, the following R00 Specific Aim will be
completed:

R00 Aim will determine, using a 10-day tDCS intervention, a) the effects of tDCS targeting the
prefrontal cortex on gait and postural control and brain activation markers (i.e., blood
flow, blood oxygenation), and b) the immediate and longer-term (i.e., over a one-month
follow-up) effects on these outcomes in patients with DM or AD. Those who exhibit gait and postural
control difficulties at baseline will be randomized into real or sham (i.e., control) tDCS
intervention groups. We hypothesize that H1) the real tDCS group will exhibit an increase in gait
speed when walking and reduction of postural sway speed when standing, and an increase in brain
activation during these tasks, both immediately and over the 30-day follow-up period.

Together, these discoveries will provide insight into the cerebrovascular control of gait and
postural control in aging and age-related disease; and new therapeutic targets (i.e., blood flow
and blood oxygenation) for balance rehabilitation. Moreover, it will identify tDCS as an important
tool in balance research that may translate into a new low-cost and safe intervention for these vulnerable populations.

Public health relevance
Aging-especially when complicated by type 2 diabetes (DM) or Alzheimer's disease (AD)-alters brain function and diminishes the control of walking and standing. In this project, we will 1) establish the effects of aging, DM and AD on the relationship between the ability to walk and stand and the associated brain activation that occurs during these activities, and 2) determine if increasing brain activation using noninvasive electrical brain stimulation will result in improved walking and standing in these vulnerable populations. This proposed research will provide new insights into the control of walking and standing and provide proof-of-concept that brain stimulation can be used as a safe rehabilitative strategy in aging and age-related disease.